Cortical feedback to the vestibular brainstem

? DESCRIPTION (provided by applicant): The goal of this R21 application is to understand the nature of feedback from cortex to early sensory areas. Specifically, our goal is the theoretical development and testing of computational models of how feedback from the vestibular cortex to the vestibular brainstem affects the perception of translation (heading). We propose to understand how inactivation of the parieto-insular vestibular cortex (PIVC), which increases perceptual heading thresholds, alters the response properties of neurons in the vestibular nuclei. The best known correlational link between sensory neural responses and perceptual choice is known as the `choice probability'. Relevant to the origin of choice probabilities is the amount of `shared noise' among neurons, which is measured as interneuronal correlation of spike rates (`noise correlations'). First, using mechanistic models, we will generalize previously identified relationships between neural tuning, noise correlations, and choice probabilities to network architectures that incorporate recurrent connectivity. Second, we will compare various normative models that specify the function and form of neural feedback for our tasks, and derive from them predictions for the same experimental quantities. We will then test the predictions of these theories on data (neural sensitivities, choice probabilities and noise correlations) recorded from vestibular nuclei neurons before and after PIVC inactivation. Results from these studies are critical for understanding how sensory signals contribute to perception. Showing that perceptual, choice-driven signals are fed back onto the early sensory areas that themselves provide the main contributions to the thalamo-cortical network will provide valuable new insights about `active sensing' and how perception arises from the coordinated activity of multiple interconnected loops and networks.

Public health relevance
PUBLIC HEALTH RELEVANCE: Vestibular deficits lead to profound postural instability and loss of spatial orientation. Neurological correlates of spatial orientation disorders are still a mystery, posing a major hurdle in defining effective therapeutic strategies. Understanding the feedback signals from the vestibular cortex to the vestibular brainstem, as well as the perceptual-related properties of the central vestibular system are vital for understanding and treating basic postural and spatial orientation deficits.